Hyopthyroidism Treatment in Aging and Thyroid Cancer

DESCRIPTION (provided by applicant): Thyroid disease represents a significant medical and public health challenge in the United States affecting over 19 million Americans. Hypothyroidism (HT) found in 4.6% of the US population, is increasingly common in the elderly affecting more than 20% of women and 11% of men. Hypothyroidism is defined by an elevated serum thyroid stimulating hormone (TSH) concentration with low serum thyroxine (T4) and tri- iodothyronine (T3) concentrations. Population studies demonstrate an age-related elevation in TSH concentrations, but at present, there is no consensus regarding the TSH concentration at which replacement therapy should be initiated. Another significant gap in knowledge is a lack of pharmacokinetic data of levothyroxine specifically in aging. The presence of endogenous thyroxine makes it impossible to differentiate between internally and externally-derived thyroxine using conventional laboratory tests. In Aims 1 we will conduct pharmacokinetic studies of 13C-LT4 in the elderly. We have designed and validated this method, using state-of- the-art technology, which permit the measurement of exogenous LT4 and conduct pharmacokinetic studies of single dose oral LT4 replacement. A secondary aim (Aim 2) will examine the bioactivity of TSH, assuming the age-related elevation in TSH concentrations consists of relatively more inactive TSH. Aim 3 will examine age-related thyroid hormone activity in peripheral tissues reflecting drug effectiveness. Our experience in patient recruitment and conducting PK studies using state-of-the- art liquid chromatography tandem mass spectrometry (LC/MS/MS) at Georgetown University Medical Center (GUMC), as well as our preliminary data, assure the success of this proposal. If the goals of this research are achieved it will advance the knowledge in the field and have a major impact on the aging population; with the aging of America's baby boomers the need to fully understand the progression thyroid disease, to improve diagnosis and treatment is vitally important to our nation and to our healthcare systems. We believe that these unique and innovative studies will provide a wealth of information that will translate to improved diagnosis, evaluation and management of therapeutic interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Thyroid disease represents a significant medical and public health challenge in the United States affecting over 19 million Americans. In order to diagnose, treat and manage hypothyroid disease appropriately we need elucidate and characterize the age- associated differences in thyroid hormone metabolism, especially in women. This will help in setting therapeutic goals and help millions in diagnosis, treatment and management of thyroid disease in aging. Project Narrative Thyroid disease represents a significant medical and public health challenge in the United States affecting over 19 million Americans. In order to diagnose, treat and manage hypothyroid disease appropriately we need elucidate and characterize the age- associated differences in thyroid hormone metabolism, especially in women. This will help in setting therapeutic goals and help millions in diagnosis, treatment and management of thyroid disease in aging. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The overall goal of this project is to assess the adequacy of thyroid hormone replacement with levothyroxine (LT4) in elderly hypothyroid patients and those who may have drug-induced subclinical hypothyroidism (SH). The thyroid hormones thyroxine (T4) and triidothyronine (T3) have profound effects on mood and behavior, cellular metabolism, growth and differentiation. Thyroid function changes with advancing age [8], and confounding factors such as autoimmune subclinical hypothyroid disease, chronic (non-thyroidal) illness and medication-induced modifications in thyroid function also may be present. As a result, elderly hypothyroid patients present a unique clinical challenge, since optimal dosing regimens developed for younger persons cannot be directly extrapolated. To address these issues, we propose the following Aims: Aim 1. To determine whether LT4 pharmacokinetics are altered in elderly patients receiving LT4 replacement for hypothyroidism, when compared with younger individuals. We hypothesize that changes in LT4 bioavailability or clearance, if better defined, would alter empiric treatment and therapeutic monitoring of LT4-replaced elderly patients. We will use our novel LC/MS/MS methods, and carbon -13- labeled LT4 tracer (13C-LT4) to assess intensively-sampled serial PK (a within-subjects design) in elderly and non-elderly adults. In our Preliminary Data, we describe how we developed a unique preparation of 13C-LT4 suitable for human use, in single-dose PK studies during pregnancy [13, 14]. We will conduct pharmacokinetic studies of 13C-LT4 in thyroidectomized men and women over 70 years old taking daily exogenous LT4 replacement. Similar studies will be conducted on hypothyroid subjects with an intact but underactive thyroid on LT4 replacement. We will analyze serum T4/T3/FT4/FT3 using LC/MS/MS and will measure serum TSH, anti-thyroid peroxidase (TPOAb), and anti-thyroglobulin antibodies (TgAb). Serum samples from our preliminary studies of levothyroxine-replaced women (25 to 40 years old) will be a comparison group for metabolite concentrations. Already completed detailed PK analyses in these women will be compared to the data in our elderly population. All subjects will complete a "hypothyroid symptom scale" survey to assess correlation of hormonal parameters with clinical findings. Recent epidemiologic studies have suggested that elderly patients with a TSH above the normal reference range for younger individuals may, in fact, have beneficial clinical outcomes. It is possible that in the elderly serum TSH is relatively bioinactive or that serum hormone levels do not accurately reflect peripheral thyroid hormone action; the following secondary aims examine these possibilities. Aim 2: To assess TSH bioactivity in patients e70 years old with serum TSH concentrations between 0.5-3.0 mIU/L, compared to a group with serum TSH concentrations between 5.0-10.0 mIU/L. We hypothesize that elevated serum TSH concentrations observed in epidemiological studies and associated with aging may stem from the presence of biologically inactive TSH. We will conduct TSH bioactivity studies to distinguish authentic subclinical hypothyroidism in the elderly from artifacts related to TSH immunometric measurements. Aim 3: To examine thyroid hormone action in elderly patients with serum TSH concentrations between 0.5-3.0 mIU/L and elderly patients with serum TSH concentrations between 5.0-10.0 mIU/L. We hypothesize thyroid hormone action will decrease with age and that serum thyroid hormone levels do not accurately reflect peripheral thyroid hormone action. Biomarkers of thyroid hormone action at the tissue level will include serum ACE, ferritin and SHBG concentrations. Clinical symptoms of thyroid dysfunction can be subtle and inconsistent. This heightens the importance of reliable biochemical laboratory definitions to better detect apparent and subclinical (mild) thyroid disease. To that end, our ability to detect small changes in thyroid dysfunction has improved with sophisticated technology, highly sensitive and specific detection methods, and deeper understanding of thyroid hormone metabolism. We will employ all 3 approaches in this application, to provide a more complete and accurate picture of the significance of thyroid hormones in the elderly.